Shared Resources Core

SHARED RESOURCES CORE: SUMMARY
The Shared Resources Core (SRC) is structured as a physical shared resource that will support both Research
Projects, the PDX Core, as well as pilot and trans-Network projects. The most critical goal of the SRC is to
provide services and resources that are either unavailable to individual research teams within PDXNet or that
are unable to meet the cost, technical, and speed requirements of the Projects and other components at WU-
PDTC. Other important missions for the SRC include optimization of the procedures for project/sample-specific
requirements, standardization of the assays to ensure data consistency, and incorporation of the latest
technologies. This centralized arrangement takes full advantage of the expertise and infrastructure existing at
our institute developed through participation in several large-scale NIH consortia, including HTAN (Human Tumor
Atlas Network), SenNet (Senescence Network), GUDMAP (GenitoUrinary Development Molecular Anatomy
Project), CPTAC (Clinical Proteomic Tumor Analysis Consortium), PE-CGS (Participant Engagement and
Cancer Genome Sequencing), CRIP (Co-Clinical Imaging Research Program), and PDXNet, in order to increase
effectiveness and efficiency, avoid duplicated effort, and reduce stress on individual projects. SRC will be tightly
integrated with the Research Projects, Pilot and Trans-Network Projects, the PDX Core, and the Bioinformatics
Core under the supervision of the Administrative Core. Detailed characterization of the PDX tumors at the DNA,
RNA, and protein levels will be important for validation, model selection, revelation of molecular changes in
response to treatment, illustration of mechanisms of treatment resistance, as well as the identification of
biomarkers and targets for future treatment testing. To accomplish these goals, the SRC will work with the
Research Projects and other Cores to perform two main types of assays: Omics and imaging. For omics, the
SRC will cover bulk and single cell omics, including whole exome sequencing (WES), bulk RNA-seq, single
nucleus RNA-seq and ATAC-seq (snRNA-seq and snATAC-seq), spatial transcriptomics (Visium), as well as
global proteomics and phospho-proteomics. For imaging, the SRC covers multiplex target imaging
(CODEX/Phenocycler), in vivo preclinical molecular and radiologic imaging, and standard immunofluorescence
(IF) staining. The SRC is also tasked with adjusting to the changing needs of the projects as well as introducing
new technologies and tools to assist the Projects and to accomplish the mission of the center.